Identification of post-translationally modified antigens using genetic code expansion

PROJECT SUMMARY
Post-translational modifications (PTMs) are chemical modifications of amino acid side chains in proteins. PTMs
are indispensable for biological processes and are intimately involved in numerous diseases. Post-translational
modifications of proteins lead to alteration of their biochemical properties and are a crucial component of many
cellular processes. Interestingly, PTMs also alter the immunogenicity of proteins by positively or negatively
influencing recognition by antibodies or T cells. In particular, PTM epitopes have been shown to alter presentation
of epitopes on MHC/HLA molecules and their recognition by T cells. PTMs such as deamidations, Hybrid Insulin
Peptide (HIP) formation, citrullination, and phosphorylation have been known to create immunogenic epitopes
across many diseases including Rheumatoid Arthritis, Type 1 Diabetes, and cancer. Despite their recognized
importance, there is a lack of robust, scalable, and high-throughput approaches to interrogate PTMs as T cell
antigens. We have previously developed a cell-based T cell antigen discovery approach called SABRs that can
present >10,000 epitopes to T cells and identify their cognate epitopes. Using SABR libraries, we have previously
identified novel HIPs as autoantigens in Type 1 Diabetes and personalized neoepitopes in melanoma. Here, we
propose to build upon this platform for the identification of PTM epitopes. We will employ genetic code expansion
to use orthogonal tRNA/tRNA synthetases to site-specifically incorporate PTMs in genetically-encoded SABR
libraries. Our preliminary studies have demonstrated the feasibility of this approach in incorporating modified
lysine and citrulline into epitopes. We aim to: 1) extend this platform to incorporate phosphorylated serine,
acetylated lysine, and trimethylated lysine into SABRs; and 2) use this approach to identify citrullinated
autoantigens in Type 1 Diabetes. Successful completion of this project will establish a robust, scalable, and
versatile platform capable of presenting thousands of epitopes with precisely defined PTMs. These studies will
pave the way for interrogating PTM epitopes at unprecedented scale, will lead to identification of neoepitopes
across multiple diseases including autoimmune disorders and cancers, and enhance our mechanistic
understanding of the immunological consequences of PTMs.

Public health relevance
PROJECT NARRATIVE Post-translational modifications of proteins are indispensable for biological processes and are known to be present in important antigens recognized by T cells. Our goal is to develop a novel methodology at the intersection of synthetic biology and immunology to interrogate these antigens. Successful completion of these studies will fulfill an unmet need for identification of post-translationally modified antigens across many diseases, including autoimmunity and cancers.